Brain dynamics underlying long-term memory consolidation

Abstract
The hippocampus has a well-established role in the initial formation and storage of memory.
However, little is understood about brain mechanisms that support the re-organization and
transfer of memories into longer-term cortical storage. A detailed understanding of hippocampal-
to-cortical consolidation is critical to shed light on the regulation of long-term memories, and how
they may become too transient (as in Alzheimer’s, Parkinson’s, Traumatic Brain Injury) or too
persistent (as in PTSD). One challenge has been the difficulty inherent to tracking the real-time
cellular resolution activity of multiple brain regions throughout the weeks-to-months long
consolidation window. Toward this, we have recently developed a head-fixed behavioral
paradigm, compatible with longitudinal imaging, where mice learn to form and main contextual
associations for at least one month. We have also found that learning of this task requires the
hippocampus, while memory consolidation requires the entorhinal and prefrontal cortex. Using
methods to perform multi-region longitudinal neural activity recordings, together with
anatomically-defined optogenetic inhibition during imaging, we propose to dissect the real-time
contributions of the hippocampal-entorhinal-prefrontal pathway in memory consolidation.
Specifically, we aim to characterize a new behavioral model of memory consolidation (aim 1), and
perform longitudinal imaging to identify prefrontal cortex brain activity patterns unique to
consolidated memories (aim 2). Finally, we will identify how entorhinal projections stabilize such
activity patterns in prefrontal cortex during consolidation (aim 3). Together, we will contribute to
our understanding of how some memories are progressively re-organized and stabilized across
the brain for long-term storage.

Public health relevance
Project Narrative Memory consolidation is the gradual process of re-organizing memory representations from their initial sites of encoding to more permanent storage. This process is disrupted in many neurological and psychiatric conditions, however, due to technical limitations, little is understood about this weeks-to-months long brain reorganization process. Here we develop new behavioral paradigms and methods for chronic recording of relevant brain regions for at least one month to gain insight into how some memories are forgotten while others are progressively stabilized.